ASHA 2: An Ethnographic Study Embedded in a Depression Treatment Trial

A leading cause of global disability, depression is widespread among women in low- and middle-income
countries (LMIC). Poverty is a major cause of depression, while depression worsens poverty, compromising
economic productivity. Funded by NIMH’s Global Brain Initiative, the ASHA Project is a groundbreaking
research study that seeks to address the poverty-depression syndemic among rural Bangladeshi women using an
integrated intervention model with both psychological and economic treatment. The project is a two-arm cluster
randomized clinical trial carried out in villages in the Rangpur district of northern Bangladesh—a flood prone
region with high rates of rural poverty. Treatment groups of 12-15 women, led by village health workers, will be
cluster-randomized into the integrated intervention arm (cash/asset transfer plus Problem Management (PM)+--a
group-based, manualized psychotherapy) or to PM+ alone.
This application proposes to embed an ethnographic study inside the ASHA RCT. Led by an
interdisciplinary team of psychologists, anthropologists, and maternal health specialists in the US and
Bangladesh, the study will investigate the complex relationships between ASHA intervention processes and
outcomes, and social contexts at the individual, household, neighborhood, and village levels. Although
ethnographic inquiry—the holistic study of local sociocultural contexts—is well suited to the generation of new
knowledge, ethnographic studies are rarely integrated into mental health treatment trials. The research team will
use a rapid ethnography (RE) approach to conduct qualitative interviews, focus groups, and structured
observations, including salient local attributes such as presence of schools, clinics, and roads, alongside
observations about how everyday life and governance is organized. A comparative analysis will examine
differences across study arms (integrated vs psychotherapy alone), participant engagement (retention/vs attrition)
and clinical outcomes (treatment response vs none). This will allow for the generation of hypotheses about key
moderating and mediating variables affecting outcomes.
A capacity building program will train three young graduates in anthropology from a local university in
Rangpur, providing both didactic training in Dhaka as well as hands on supervision in data collection in the
field. Fellows will receive training in data collection, clinical trial design, research ethnics and data analysis.
Fellows will receive mentoring and support in obtaining research positions.

Public health relevance
Depression is at epidemic levels among low income women in rural Bangladesh. Poverty plays a major role. The ASHA RCT tests an integrated depression treatment model-- combining depression treatment with poverty alleviation—to standard depression treatment alone, for depressed, low-income women in 40 villages across the Rangpur region of North Bangladesh. The study proposed in this application will embed an ethnographic study inside the ongoing ASHA trial. Through interviews, focus groups and participant observations of four villages, investigators will examine the socio-cultural and contextual factors that affect/modify treatment impact and engagement. A capacity building project will train several young anthropologists in mixed methods heath research.